Therapeutic targeting of VHL-deficient clear cell renal cell carcinoma

Project Summary/Abstract
Synthetic lethality screens hold great promise for cancer therapy since they enable the identification of
chemical compounds that selectively target tumor cells while sparing normal tissue. This approach presumes
that cancer cells harboring a specific mutation will be more sensitive to manipulation of certain pathways than
normal cells that lack the mutation. The von Hippel-Lindau (VHL) tumor-suppressor gene is functionally lost in
about 90% of Clear Cell Renal Cell Carcinomas (ccRCCs). Because VHL-deficient ccRCCs resist current
therapies and frequently metastasize, identifying effective new therapies will be crucial for achieving long-
lasting responses. This project’s long-term goal is to therapeutically target VHL-deficient ccRCCs using a
synthetic lethality approach, and to move the most promising therapeutics to clinical trials. Here we propose
to investigate cyclin-dependent kinase (CDK) inhibitors as synthetic lethality-based therapeutics for targeting
ccRCC. We have validated a multi-CDK inhibitor—Dinaciclib—as a therapeutic candidate with potent in vivo
activity in a patient-derived xenograft (PDX)-based orthotopic mouse model of ccRCC. Our preliminary data
indicate that several specific CDK9 inhibitors (CDK9i)—AZD4573, NVP-2, and KB-0742—mimic Dinaciclib-
induced death of VHL-deficient cells in vitro. CDK9 represents a promising therapeutic target since: (1) it is a
non-canonical CDK regulating RNA polymerase II-mediated transcription; (2) multiple CDK9i have been
developed, with several undergoing clinical trials in cancers other than ccRCC. Accordingly, our goal is to
evaluate AZD4573 as a potential therapeutic for ccRCC. Our objectives are to dissect the mechanism of
synthetic lethality in vitro, and assess AZD4573 efficacy in vivo, including its effects on anti-tumor immunity.
We propose the following Specific Aims: 1) Dissect the mechanism of synthetic lethality of CDK9 inhibition
with VHL loss in vitro, where we will test the hypothesis that there is a cross-talk between VHL and CDK9
pathways, affecting each other’s activity. We will also test the involvement of several candidate pathways
downstream of CDK9 (MCL-1 and Bfl-1 pro-survival proteins) and VHL (HIF-1 and HIF-2) in synthetic lethality
to determine the biomarkers of tumor response; and 2) Evaluate CDK inhibitor AZD4573 as a potential
therapeutic in an orthotopic PDX-based and immunocompetent models of ccRCC, the latter conducted in
combination with immune checkpoint inhibitor (ICI)—anti-PD1. ICIs represent a current front-line treatment for
ccRCC, and literature indicates that CDK inhibition by Dinaciclib and a specific CDK9i induce anti-tumor
immunity, potentiating their anti-tumor effects. Accordingly, our working hypothesis is that CDK9i will slow the
tumor growth in immunodeficient model and cause tumor regression in immunocompetent model, especially
when combined with ICI. Successful completion of the experimental plan will provide an efficient therapeutic
strategy for VHL-deficient ccRCC—CDK9i + ICI combination treatment. Dissecting the mechanism of synthetic
lethality will allow for patient stratification into potential responders and non-responders.

Public health relevance
Narrative Clear Cell Renal Cell Carcinoma (ccRCC) is a devastating disease that is projected to affect 81,800 individuals within the USA in 2023, with a complete response rate to current treatments being only 16%. Over 90% of ccRCC patients harbor genetic alterations of the von Hippel-Lindau (VHL) tumor-suppressor gene. In this proposal we aim to assess a compound that inhibits cyclin dependent kinase 9 (CDK9) as a therapeutic to selectively target ccRCC with VHL alterations.